Neuropathology-Core

Project Summary: Neuropathology Core
The Neuropathology Core is aligned to support the overall specific aims of the OADRC's 5 overarching aims:
1) Catalyze and sustain innovative research and discovery in Alzheimer’s disease and related dementias
(ADRD) through an organizational infrastructure supporting a rich collaborative environment; 2) Focus
resources toward specific areas of emphasis: (1) Preclinical dementia and activity of disease emphasizing high
risk populations, including Black/African Americans (AA), oldest old, and isolated adults (e.g., rural, living
alone); (2) markers of meaningful change captured through studies of peripheral biomarkers, neuroimaging
and continuous in-home behavioral monitoring including known biological drivers of ADRD-pathology such as
sleep; (3) neuropathology of brain aging and late life dementia; (4) Novel testing of novel treatments and
patient and caregiver support strategies; and (5) Improving education and knowledge about dementia; 3)
Provide materials to support the science through well-characterized research participants, biological
specimens, brain tissue, data provision and analytics; 4) Contribute to the national research commons relevant
to AD and related disorders; and 5) Provide venues and mechanisms for education and training of new
scientists, as well as bidirectional engagement with key stakeholders.
The focus of the OADRC’s Neuropathology Core on the transition from healthy aging to dementia has led to the
accumulation of a large repository of tissue from cognitively intact brain donors and from those who develop
dementia and milder impairments at a more advanced age, with pathologies that differ somewhat from those of
“classic” Alzheimer’s disease. Understanding these changes in the context of the clinical and imaging findings
in these individuals is proposed as the scientific “leitmotif” around which the Specific Aims are constructed.
These are to:
1. Provide standardized research assessments while at the same time affording this diagnostic expertise to
the population of OADRC participants by providing family members of the deceased and clinicians involved
in their care with timely autopsy reports based on the most current standardized diagnostic criteria.
2. Facilitate research by collecting, storing and distributing a highly accessible, but appropriately safeguarded,
repository of well-prepared brain tissue and neuropathologic data from carefully and longitudinally
characterized patients with mild cognitive impairment (MCI) or dementia as well as non-cognitively impaired
individuals using a variety of methods that maximizes utility to scientists.
3. Teach trainees in pathology, neurology, psychology, psychiatry, and basic sciences the current methods of
neuropathological classification of neurodegenerative diseases and age-related changes, and mentor
faculty in NP.
4. Develop innovative new approaches to maximize achievements in Aims 1 to 3.